In Vivo Testing and Statistics Core

Core B has four goals: [unreadable] The first goal is to perform bioluminescent imaging of luciferase. [unreadable] The second goal is to help coordinate, supervise and oversee all animal studies for all five projects and to conduct all of the normal tissue toxicology testing where required. [unreadable] The third goal of the project is to provide a centralized cell line, medium and serum bank to ensure uniformity as much as possible between the test systems used by all of the projects. The Core will also perform the serum testing and mycoplasma testing of the cell lines used by all the projects. [unreadable] The fourth goal is to provide statistical support for all of the projects in the Program Project